MYOCARDIAL ADAPTATION TO EXERCISE

The proposed studies will investigate further the mechanisms by which the myocardium adapts to endurance exercise. The experiments will focus on compositional and functional adaptations of cardiac sarcolemmal (SL) and sarcoplasmic reticulum (SR) membranes in response to training. Rats will be treadmill trained in a progressive fashion for a period of ten weeks using a protocol that we have shown previously induces a compositional change in myocardial SL and augments contractility. Lipids will be extracted from both highly purified SL and SR membranes and crude homogenates for phospholipid and fatty acid analysis by high performance liquid chromatography (HPLC). Calcium transport will be determined as Na+dependent Ca++ uptake in SL vesicles (Na+/Ca++ exchange) and AT-dependent Ca++ uptake in SR vesicles. Under the appropriate conditions the Km and Vmax of these systems can be determined and compared between trained and control hearts. Ca++ binding of these membranes will also be determined. Membrane enzyme markers will be used to denote preparation purification and also to determine possible fluidity changes that may accompany the compositional adaptation to exercise. The sarcolemmal enzymes adenylate cyclase, Na+ K+ ATPase and K+ p-nitrophenyl phosphatase as well as Na/Ca++ exchange will be assayed as a function of temperature (10-40 C). Arrhenius plots of these data in addition to that from SR Ca++ ATPase and Ca++ uptake should indicate whether shifts in phase transition points have occurred in response to training. In order to investigate the possibility of exercise-induced protection against the adverse effects of myocardial ischemia, an in vitro model will be utilized. Recently, several reports have indicated that ischemia can rather rapidly induce alterations in sarcolemmal composition and function. Furthermore, these SL modifications have been implicated in the etiology of myocardial dysfunction resulting from ischemia. Since it has been shown that exercise can alter cardiac sarcolemmal composition, this proposal will investigate the hypothesis that exercise training can provide protection against the deleterious effects of myocardial ischemia.